Origin and Function of Double Negative T cells in Lupus

SUMMARY. Loss of B cell tolerance and production of auto-antibodies (Ab) by plasma cells (PCs) play a major
role in Systemic Lupus Erythematosus (SLE) pathology. Though Ab-dependent pathogenesis can be partially
controlled with immunosuppression, there is no cure for Ab-mediated disorders. One of the main limitations
when developing therapeutic strategies aimed to prevent Ab-dependent pathology is the lack of a precise
understanding of how auto-reactive PCs are generated and maintained. In this regard, T follicular helper (Tfh)
cells, a subset of CD4+ T cells that provides help to B cells, play a critical role in promoting auto-reactive PCs.
As such, the expansion of self-reactive Tfh cells correlates with auto-Ab production and disease severity in
murine and human lupus. Similar to Tfh cells, Double-negative (DN) T cells, a particular population of T cells
that characteristically lack CD4 and CD8 expression, are also expanded in lupus. Importantly, the frequency of
DN T cells also correlates with disease activity and auto-Ab production. Thus, it is generally believed that these
cells play a role in autoimmune disease pathogenesis. Despite their putative role in disease development, we
do not know what signals control DN T cell formation, and their exact origin and pathogenic function remain
largely elusive. Furthermore, the mechanisms that regulate DN T cell homeostasis are entirely unknown, and
there are currently no therapies to selectively deplete DN T cells in vivo. The main goal of this proposal is to
define the cellular and molecular mechanisms that control pathogenic DN T cell development and function. In
this regard, our preliminary data demonstrate that DN T cells and Tfh cells share phenotypic, transcriptional,
and developmental requirements. As such, we have identified a population of Bcl6+ DN T cells that
phenotypically resemble Tfh cells. The central hypothesis that will be tested in this proposal is that Tfh cells are
the precursors of Bcl6+ DN T cells and that, similar to Tfh cells, these cells are efficient B cell helpers.
Importantly, our preliminary data also suggest that Bcl6+ DN T cells are more plastic than Tfh cells, which
allows them to acquire a “hybrid” Tfh/Th17 signature that we believe is critical for supporting auto-reactive PC
responses. In Aim 1, we will test the hypothesis that Tfh cells are precursors of Bcl6+ DN T cells and examine
the capacity of these cells to help self-reactive B cell responses. In Aim 2.1, we will test the hypothesis that IL-
17 production by DN T cells is critical for supporting PC responses and Ab-mediated pathology. In Aim 2.2, we
will determine the molecular mechanisms controlling the acquisition of a “hybrid” Tfh/Th17 signature. Finally, in
Aim 3, we will develop a new synergistic IL-2-based immunotherapy aimed to selectively target Tfh and
prevent the differentiation of IL-17+Bcl6+DN T cells by combining “ultra-low” doses of rIL-2 with STAT3-
signaling blockade. We believe that our studies will provide a new paradigm for how pathogenic DN T cells are
generated, will reveal new pathways implicated in autoimmune disease pathogenesis, and will be crucial for
designing new therapeutic interventions to target Tfh and DN T cells and prevent Ab-mediated pathology.

Public health relevance
PROJECT NARRATIVE Double-negative T cells are a rare population of T cells that lack CD4 and CD8 expression and abnormally expand in lupus patients. While current studies demonstrate that DN T cells play an important pathogenic role in autoimmune disease development, the mechanisms that regulate DN T cell homeostasis are completely unknown and there are no therapies to selectively deplete DN T cells in vivo. In this proposal, we will define the cellular and molecular mechanisms that control DN T cell development and function, and we will develop a novel mechanism-based immunotherapy to deplete DN T cells.